Hutchinson Center as Lead Academic Participating Site (UG1)

Project Summary/ Abstract
The goal of the NCI National Clinical Trials Network (NCTN) is to develop and conduct state-of-the-art cancer
treatment and advanced imaging clinical trials, especially large, definitive multi-institutional trials evaluating
new cancer therapies and related clinical approaches. NCTN Lead Academic Participating Sites (LAPS) are
one component of this network and will provide scientific leadership in the development and conduct of NCTN
clinical trials in association with one or more adult Network Groups as well as substantial accrual to clinical
trials conducted across the entire NTCN. The Fred Hutchinson Cancer Research Center (Fred Hutch) is
among the nation’s leading cancer centers and is the only NCI-designated comprehensive cancer research
center serving the WWAMI (Washington, Wyoming, Alaska, Montana and Idaho) region. The broad and deep
pre-clinical and clinical research programs at Fred Hutch will support the NCTN Program in three major ways:
(1) The scientific expertise of the members of Fred Hutch will continue to contribute to the leadership of the
NCTN program through their activities directly at the NCI and in SWOG, NRG and ACRIN. (2) The innovative
pre-clinical and clinical research studies at Fred Hutch will provide the preliminary information necessary to
shape the next generation of cooperative group trials. (3) The large patient base at Fred Hutch combined with
expert clinicians and clinical trials infrastructure will assure substantial accrual to NCTN trials. Fred Hutchinson
Cancer Research Center and its partners are committed to the goals of the National Clinical Trials Network
(NCTN) and will work to provide leadership for our nation’s clinical trials network.

Public health relevance
Project Narrative In 2017, approximately 1.68 million individuals in the United States will be diagnosed with cancer and almost 601,000 people will die of the disease. Clearly, new approaches to cancer prevention, diagnosis, and treatment are needed and these will only come from new insights achieved through research. As one of the leading cancer research centers in the country, the Fred Hutchinson Cancer Research Center can help provide leadership for, and participation in our nation’s clinical trials network.